Development of Investigators Supporting Community Outreach and Value of Engagement in health disparities Research (DISCOVER)

PROJECT SUMMARY/ABSTRACT
The
Development of Investigators Supporting Community Outreach and Value of Engagement in health
disparities Research (DISCOVER)
program will support and sustain early career health equity investigators that
conduct research for Black/African American or Hispanic/Latino Washington, DC residents that experience
health inequities in cancer, stroke and maternal health. The Community Engagement and Dissemination Core
(CEDC) is responsible for outreach, engagement, communication and dissemination of results for Georgetown’s
P50 Center for Excellence
. The CEDC
will facilitate investigators’ efforts to build equitable, sustainable,
meaningful, and collaborative relationships with DC community members. In collaboration with the Community
Advisory Board and Investigator Development Core, the CEDC will design work with early career investigators
to engage with members of the Washington DC community, share results and, ultimately, strive to implement
results from research into sustainable change. Community engagement requires investigators to learn cultural
humility, how to create equitable partnerships, identify and approach community partners, create equitable
research budgets, and design relevant outreach materials. The CECD will develop and implement methods and
structures for investigators to engage with community members. This will include overseeing the engagement of
community members in DISCOVER’s activities such as community members’ participation in a launch meeting
and “Idea Lab” sessions where investigators brainstorm ideas. The CEDC will partner with many DC based
organizations such as Nueva Vida (Latino cancer), the Stroke Comeback Club, and Community of Hope (Black
maternal health). These community meetings will be structured to maximize co-learning and equitable dialogue
and minimize power differentials. CEDC will also lead community-based rotations for early career investigators
to gain experience in community engagement. Finally, the CEDC will be responsible for providing
recommendations and best practices for dissemination of information from DISCOVER research to the
community across multiple levels, including: overseeing and supporting investigators holding community grand
rounds, distributing newsletters to relevant community partners, and sharing health disparities research with
other DC stakeholders. The CEDC will enrich not only the experiences of early career investigators focused on
health disparities research, but also the health and well-being of racially minoritized DC residents who experience
health disparities in cancer, stroke and maternal health.